ONCOGENE EXPRESSION IN CELL LINES DERIVED FROM HUMAN HEPATOCELLULAR CARCINOMA

The possible role of oncogenes in the development of human hepatocellular carcinoma (HCC) has not been well defined. We have examined several cell lines from human HCC, as well as a control (non-HCC) cell line (WI-38) for levels of expression of oncogenes. HCC cell lines included two with integrated hepatitis B virus (HBV) DNA sequences and one without HBV DNA. Oncogene expression was evaluated using northern blot and dot blot hybridization. In studies completed to date, expression of H-ras, K-ras, N-ras, and c-myc were similar in the three HCC cell lines; observed differences were not attributable to the presence or absence of integrated HBV.